Characterization of sarcopenia in heart failure by T1rho magnetic resonance fingerprinting

Project Summary
The goals of this proposal are to develop a novel quantitative magnetic resonance imaging (MRI) technology
for characterization of sarcopenia, loss of skeletal muscle mass and function, in heart failure (HF) and support
the career development of the investigator, Brendan Eck, PhD, in aging and biomedical imaging research.
Research: Sarcopenia in HF is independently predictive of poor outcomes. Although primary sarcopenia is a
condition of aging, rates of sarcopenia in HF are greater than the general population. Pathophysiological
mechanisms in the heart and skeletal muscle have been identified that link HF and sarcopenia. Current tools
for assessing sarcopenia in HF are indirect or are not sensitive to alterations in skeletal muscle that occur early
in disease. Quantitative MRI can provide tissue property measurements that are potentially sensitive to
pathological changes in skeletal muscle. However, existing techniques are impracticably slow or not
reproducible. MR fingerprinting (MRF) has developed as a rapid, reproducible technique for quantification of
multiple tissue properties. However, quantitative T1rho, a measure sensitive to alterations in protein content,
has only recently been shown to be quantifiable by MRF with no study of its use in sarcopenia. This project
aims to develop T1rho-MRF to simultaneously quantify T1rho and other MRF-derived skeletal muscle
properties. T1rho-MRF will also be developed for cardiac imaging to investigate tissue alterations affecting
both skeletal muscle and myocardium in sarcopenia with HF. In Aim 1 of the project, the T1rho-MRF
technology will be developed and optimized in simulations. T1rho-MRF will be validated in physical phantoms
and in human subjects. Skeletal muscle biopsy will also be acquired and T1rho-MRF will be compared to
tissue properties such as fiber type proportion. In Aim 2, healthy controls and HF patients, with sarcopenia and
without sarcopenia, will be scanned with T1rho-MRF. Quantitative values will be compared between groups to
characterize HF patients with sarcopenia. T1rho-MRF measurements will be correlated with function from grip
strength, 6-minute walk, and cardiopulmonary tests.
Career development: The investigator has a technical background in quantitative cardiovascular imaging and
aims to transition to aging and biomedical imaging research. This research project develops critical skills and
knowledge for the investigator’s career development. The career development plan provides training in biology
of aging, biology of skeletal muscle, engagement with clinicians to understand clinical assessments of
sarcopenia in HF, and imaging research study design and execution. Training includes both didactic and
experiential components. A diverse mentorship team, consultant, and collaborators contribute complementary
skills toward developing the candidate’s interdisciplinary research program.
Summary: The proposal will provide novel imaging tools to assess sarcopenia in HF and support the career
development of the investigator to become an independent researcher in aging and biomedical imaging.

Public health relevance
Project Narrative Heart failure represents one of the most significant burdens to patients of advanced age and often presents with sarcopenia, or muscle wasting, which is independently predictive of poor outcomes. The objective of this project is to develop a novel quantitative magnetic resonance imaging technology and use it to characterize the skeletal muscle and myocardium in heart failure patients with sarcopenia. This project will advance the career development pursued by the investigator as well as provide a novel imaging tool that can help to improve the assessment, and potentially the clinical management, of heart failure patients with sarcopenia.